Role of uptake2 in neuroprotective signaling

Project Summary/Abstract
This project is a diversity supplement to the parent project R16NS129675 (Nonpeptide neurotrophic
mechanisms in spinal cord repair). The supplement will extend the scope of the parent project and provide
training opportunities for an outstanding master’s degree candidate in preparation for subsequent enrollment in
a doctoral program. The overall goal of the parent project is to increase understanding of neuroregenerative
mechanisms and uncover novel pharmacological targets for the treatment of spinal cord injury (SCI). Following
rational selection and screening of small-molecule compounds, we identified several candidates having the
ability to boost neurotrophic signaling and promote regrowth of damaged nerve cells in a tissue culture model.
While the parent project will explore the molecular mechanisms of action of these compounds in
neuroregenerative models, the present supplementary project will focus on testing some of the compounds in a
cellular neuroprotection model. Specifically, the supplement project will address the question whether the
ability of the compounds to provide neuroprotection in cultured cells is dependent on prior cellular
internalization of the compounds through the postsynaptic transporter fondly designated as Uptake2, and then
probe the differential role of transcripts mediating CDP-diacylglycerol synthesis in the microsomal and
mitochondrial compartments. By addressing the neuroprotective mechanism of the compounds, the parent
project will gain a more comprehensive perspective on the development prospects of the compounds. Beyond
the planned experiments and anticipated results, the trainee will have opportunity for structured learning
experiences as part of the master’s program in translational medicine. Overall, this supplementary project is
expected to tangibly contribute to diversifying and expanding the biomedical research and practice workforce
given its expected preparation of the trainee for onward access and success in doctoral studies.

Public health relevance
Project Narrative This diversity supplement project will provide structured training and mentoring opportunities for an exceptional master’s degree candidate in preparation for subsequent doctoral level study. The supplementary research project will expand the scope of the parent project to incorporate examination of ligand internalization and transcription-dependent neuroprotection, thus giving the candidate opportunities to gain experience with multiple research methods while concurrently completing a master’s degree in translational medicine. By helping to strengthen and validate the candidate’s interest in science and preparation for doctoral studies, this project will contribute to diversifying and expanding the biomedical research workforce.